Precision, Functional Glyconanoassemblies through Supramolecular Design

PROJECT SUMMARY
Carbohydrates present an important class among the natural building blocks of biopolymers as glycan-protein
interactions participate in many essential biological processes including immune function, cell-signaling, the
recognition of pathogens, among others. Understanding the nature of these interactions has sparked a growing
interest in building synthetic glycan assemblies that can probe and mimic these natural recognition events and
inform the design of effective antiviral and therapeutic agents. Despite ongoing interest, however, existing
glycoassembly platforms such as dendrimers, nanoparticles, and polymers often face fundamental limitations
including non-uniform composition and size, lack of atomic precision, and limited architectural tunability. These
challenges hinder precise control over their molecular recognition behavior and limit our understanding of the
structure-activity paradigms essential to their function. The proposed research seeks to address these limitations
by employing a coordination-driven self-assembly approach of synthesizing multivalent glycomolecules with
atomic precision. This new supramolecular synthetic strategy advances the state-of-the-art abiotic systems by
introducing a modular and programmable method of designing key structural parameters including architectural
size, shape, charge, rigidity, and morphology, which are essential factors for probing and understanding
structure-activity relationships involved in biomacromolecular recognition. By employing a platform that offers
the topological surface density and complexity characteristic of nanoparticles with the synthetic control afforded
by small molecule systems, the proposed work aims to provide the ability to optimize glyconanoassemblies for
enhanced protein recognition and selectivity. Through this unique synthetic approach, we aim to establish a new
paradigm for studying glycan-protein recognition that provides fundamental insights into the design of therapeutic
strategies to treat conditions where multivalent interactions play a pivotal role. Because our work is positioned
at the interface of molecular synthesis, inorganic chemistry, chemical biology and materials science, we are
equipped with a vast array of tools to advance and develop this interdisciplinary program.

Public health relevance
PROJECT NARRATIVE From immune function, to cell-signaling, to the recognition of pathogens, multivalent carbohydrate-protein interactions play critical roles in complex biological processes essential to human health and the development of effective therapies. However, understanding the complex structure-activity relationships operative in these processes, which are essential for effectively mimicking and probing such interactions, remains a significant challenge. By employing a programmable synthetic platform that allows for precise and modular design of multivalent glycan assemblies, we seek to systematically explore protein-glycan recognition events, gaining insights that will drive the development of targeted therapeutics, antiviral agents, and diagnostic tools by advancing our fundamental understanding of these critical structure-activity relationships.